A Novel, Low-Cost Mobile Metabolic Measurement (M3) System

Summary/Abstract
Indirect calorimetry (IC) is based on measurement of the exchange of respiratory gases. All aerobic energy-
releasing reactions in the body use oxygen; oxygen consumption, V.O2, is proportional to energy expenditure
(EE). Research-grade IC systems measure V.O2, carbon dioxide production, V.CO2, and minute ventilation, V.E,
breath by breath and then average results over multiple breaths to obtain accurate measures of cardiorespira-
tory function. Subjects' V.O2max (i.e., maximum attainable V.O2) is the gold standard for assessing cardiorespiratory
ﬁtness (CRF). Indirect calorimetry is a part of cardiopulmonary exercise testing (CPET), providing a comprehen-
sive assessment of physiology at rest and during stress. Further, derived variables (e.g., V.E=V.CO2, V.E=V.O2) have
signiﬁcant prognostic implications. For example, V.E=V.CO2 and V.E=V.O2, which can be obtained under maximal
and submaximal conditions, provide measures of ventilatory efﬁciency; higher ratios indicate reduced breathing
efﬁciency (e.g., due to pulmonary shunting or increased dead space ventilation). Like V.O2peak (i.e., the maximum
V.O2 attained by a patient in an exercise stress test), V.E=V.CO2 and V.E=V.O2 improve with treatment/training.
In cardiac rehabilitation (CR), for example, patients with coronary artery disease or chronic heart failure
undergo supervised exercise training to improve heart health. Most CR is performed in outpatient settings,
where the lack of equipment and specially-trained staff have precluded quantitative measurement of key values.
To obtain such measures, patients have to be scheduled for CPET, which is expensive and generally not covered
by insurance after an initial test. In practice, due to the nonavailability of V.O2peak and other derived measures
in outpatient settings, suboptimal, semi-quantitative substitute measures are generally employed (e.g., 6-minute
walk test). The Mobile Metabolic Measurement (M3) system will enable this limitation to be overcome, enabling
objectively-measured V.O2, V.CO2, and V.E values to be available to provide CR patients with their initial exercise
intensities, to track their progress, and to optimize their exercise prescriptions to maximize safe progress. The
M3 system represents a substantial and practicable advance in quantitative CR patient monitoring.
Phase I Results All Phase I objectives were successfully achieved. Speciﬁcally, the statistical equivalence of
the M3 system's V.O2, V.CO2, and V.E measurements was demonstrated vis-à-vis two criterion systems: (1) the
VacuMed Metabolic Simulator with Mass Flow Controller system [158]; and (2) the Oxycon Mobile system [49].
Phase II Goal Phase II will involve: (1) developing and validating the M3 system product using the VacuMed
Metabolic Simulator, including the clinical software that will run on tablets and other computers; (2) evaluating
M3 system performance in healthy adults; and (3) evaluating M3 system performance in patients with chronic
stable coronary artery disease (CAD). Rigorous comparisons with commercial IC systems (viz., Oxycon Mobile
and Vyntus CPX metabolic cart) will be made during aerobic exercise. Performance testing will be conducted in
collaboration with the Arizona State University (healthy subjects) and the University of Virginia (CAD patients).

Public health relevance
Project Narrative The proposed M3 system will address the current gap in the availability of an inexpensive, easy-to-use, and accurate system for measuring key ventilatory quantities in healthy adults and cardiac rehabilitation (CR) settings for tracking patients' physiological responses to exercise and optimizing their exercise prescriptions. It is well documented in the literature that the key limitations of the gold-standard cardiopulmonary exercise test (CPET) are directly related to the expertise required to perform the test and its associated costs (both equipment and personnel). Outside of CR applications, the proposed M3 system will also provide a transformative technology that will not only compete in existing markets, but will serve to create new markets (e.g., hospital, sports, health and wellness applications, etc.), which will further reduce its relatively low cost due to economies of scale.